Estimating Cholera Burden with Cross-sectional Immunologic Data

Project Summary/Abstract
Cholera is an acute dehydrating diarrheal disease caused by infection with Vibrio cholerae. It is endemic in
over 50 countries, affecting up to 3 million people and causing more than 100,000 deaths annually. A renewed
global effort to fight cholera is underway, catalyzed by the large on-going epidemic in Haiti and now aided by
new generation oral cholera vaccines. Identifying key populations at high risk of cholera is essential to guide
these activities. Current methods to estimate cholera burden are largely based on clinical reporting with
infrequent microbiological confirmation. These methods are limited by the sporadic nature of outbreaks, poor
surveillance infrastructure, and fundamental uncertainties in the number of asymptomatic or mildly
symptomatic cases. Improved methods of detecting cholera exposure and risk are urgently needed. Detection
of immune responses in serum (serosurveillance) can provide a new avenue for rapid and accurate estimates
of cholera exposure and risk. We currently do not understand what immunological and clinical parameters are
most predictive of recent exposure, nor whether immune responses in areas with different levels of endemicity
are similar. In preliminary studies, we have used machine learning methods on antibody response data from
cholera patients in Bangladesh to classify whether individuals had been exposed in the previous 30-, 90-, or
360-days with high sensitivity and specificity. In this application, we propose to use longitudinal antibody
response kinetics, from populations with diverse genetic and epidemiologic profiles, paired with novel statistical
and machine learning approaches to provide generalizable tools to estimate the incidence of exposure to
Vibrio cholerae from cross sectional serosurveys. In Aim 1, we will develop models to estimate the time since
exposure to Vibrio cholerae and exposure incidence from cross-sectional antibody profiles and demographic
data using previously collected data from a cohort in Bangladesh. These results will allow us to identify the
antibodies and demographic factors that are most useful for prediction of time-since-exposure. In Aim 2, we will
collect longitudinal antibody data from a cohort of cholera cases and household contacts in Haiti to develop
models for estimating exposure incidence from cross-sectional serosurveillance. This cohort will also enable us
to compare the models developed for moderate/severe cases and mild/asymptomatic cases. In Aim 3, we will
optimize and validate field-adapted methods to measure cholera-specific antibodies, including the use of dried
blood spot and lateral flow assays. We will conduct a proof-of-concept cross-sectional serosurvey using these
methods in rural Haiti. Upon the completion of these aims, we will have provided a number of new tools for
measure of susceptibility to cholera in a population. These tools will have the potential to transform cholera
control efforts from the current reactive strategies to proactive ones, with the potential to contribute to disease
elimination.

Public health relevance
Project Narrative Cholera is a diarrheal disease affecting millions of people worldwide each year, with the majority of deaths due to cholera occurring in places with poor disease surveillance infrastructure. To optimize cholera control efforts, accurate estimates of cholera exposure and risk are needed. We propose studies using computational methods to determine how antibody decay data may help us estimate cholera exposure incidence.